IDATA STUDY DATA CLEANING AND ANALYSIS AND CANCER DATA ACCESS SYSTEM ENHANCEMENTS FOR PUBLIC USE

Support for IDATA study. Data cleaning and analysis and cancer data access system enhancements for public use.